Spatial approaches for optimizing TB active case finding: an investigation of activity spaces, mobility patterns, and local burden of disease in Nairobi, Kenya

PROJECT SUMMARY/ABSTRACT
Background: Tuberculosis (TB) remains one of the leading infectious causes of death globally, yet an estimated
3-4 million people who develop TB are not diagnosed each year. This case-detection gap critically impedes
global efforts to end the TB epidemic. Identification of individuals with suspected TB through active case finding
(ACF) and linking them to care can help to achieve earlier diagnosis and treatment and prevent onward
transmission. ACF aims to diagnose TB by screening people in the community and among persons at risk as
opposed to passive case finding which requires affected individuals with symptoms to seek care at health
facilities and then be evaluated for TB. Project: In this study, we will use spatial approaches to optimize active
case finding strategies, through three research aims: (1) employ multiple sources of human mobility and activity
space data, collected via a combination of surveys, individual geo-tracking, and aggregated cell phone locations
to pinpoint precise geographic locations within Nairobi, Kenya, with the highest potential yield for TB screening;
(2) develop a geospatial statistical model to estimate neighborhood-level local TB burden in Nairobi utilizing
serial TB prevalence survey data alongside case notifications and spatial covariates; and (3) produce an
individual-based TB transmission model to simulate the impact of spatially-targeted ACF strategies in Nairobi.
Candidate: I am an infectious diseases physician-scientist and epidemiologist with a background in global health
policy, TB and HIV epidemiology, and geospatial analysis as well as experience conducting research in South
Africa, Uganda, and Kenya. My long-term career goal is to become an independent investigator working to
develop data-driven, targeted public health strategies for controlling the TB and HIV epidemics in high-burden
settings. Career development plan: I am pursuing a K01 Career Development Award to establish my research
niche at the intersection of geospatial analysis, human mobility, and infectious diseases epidemiology, with
specific applications to TB and HIV. I seek advanced training and further research mentorship to develop
additional skills in (i) geospatial modeling, (ii) agent-based modeling, (iii) human mobility data, and (iv)
responsible conduct of research in international settings. Mentors and Environment: Dr. Jennifer Ross, an
expert in infectious disease epidemiology and geospatial modeling, will oversee my overall career development
and serve as my primary mentor. Co-mentors are Dr. David Horne, an expert on TB aerobiology and
transmission; Dr. Videlis Nduba, senior scientist at the Kenya Medical Research Institute (KEMRI); and Dr.
Abraham Flaxman, lead modeler at the Institute for Health Metrics and Evaluation (IHME). Scientific advisers
consist of Dr. Thomas Hawn (TB immunology), Dr. Jane Ong’ang’o (population-based surveys in Kenya), and
Dr. Adrian Dobra (data science & mobility data). This study will build upon an ongoing collaboration between the
University of Washington and KEMRI Centre for Respiratory Diseases Research.

Public health relevance
PROJECT NARRATIVE Tuberculosis (TB) remains one of the leading infectious causes of death globally. Active case finding (ACF) can help identify individuals with suspected TB and link them to care for earlier diagnosis, treatment, and prevention of onward transmission. This proposal aims to optimize ACF strategies by pinpointing geographic locations with the highest potential yield for TB screening, estimating neighborhood-level TB burden, and simulating the impact of spatially-targeted ACF interventions informed by mobility and activity spaces.